Integrative Health Sciences Facility Core

Integrative Health Sciences Facility Core
Project Summary
The Integrative Health Sciences Facility Core (IHSFC) supports human studies of environmental exposures and
disease causation and enhances translation of research findings. The goal of the Core is to accelerate the
transfer of basic biomedical knowledge from the laboratory to clinical applications in prevention, early detection,
new treatments and, ultimately, to prolong and enhance life. The strategies of the IHSFC include expanding
population exposure studies from regional cohorts to international cohorts, with emphasis on emerging
environmental contaminants, the development of novel statistical methods for the identification of individual and
cumulative effects, and the interactions of chemicals in a mixture. The broad sharing of data generated from
epidemiological studies is highly desirable to leverage the NIH investment in these studies and advance the field
of environmental health science as a whole. Collectively, these new initiatives are aimed at advancing precision
medicine-based disease risk assessment, monitoring, prevention and therapies. The overall objectives of the
Core for the next five years will be accomplished through 1) expert consultation services in medicine,
epidemiology, exposure science, and statistics, 2) sharing resources of cohorts with environmental exposure
data and biorepositories, 3) building a core of expertise in analysis of exposure mixtures, 4) informatics tools and
5) Integrative Thinking transdisciplinary workshops that will mesh information from various disciplines for
translation to the bedside and public health. Through providing these services and access to technologies, this
IHSFC will build capacity for research that integrates basic science with clinical research and public health. The
IHSFC will capitalize on the potential for synergy with other CEG components such as the Community
Engagement Core (CEC), the Integrated Technologies Support Core (ITSC), Bioinformatics Core and the Pilot
Projects Program (PPP) and our CTSA (Center for Clinical and Translational Science and Training, CCTST).
The IHSFC strategies are novel as they put emphasis on a transdisciplinary approach to problem solving
unanswered questions, notably those of the mechanisms of environmental exposures influencing health. We will
maximize the productivity our environmental epidemiology cohorts by showcasing them through multiple venues
and building informatics to facilitate access to their unique exposure information, data collection tools and details
of resource sharing. With expertise in bioinformatics and statistics, we will build our capacity for examining the
health effects of exposure mixtures. Our plans are tightly integrated with those of the ITSC, CEC, Bioinformatics
Core and the PPP. Our cadre of internationally recognized environmental epidemiologists and exposure
scientists model transdisciplinary research and team science for junior investigators and those new to
environmental science, promote use of the capacity building opportunities available through the ITSC and the
Bioinformatics Core, and value the new input from the multi-directional partnerships fostered by the CEC.